Alcohol Intervention Treatment Outcome Research Training

The specific aims of this postdoctoral training program are threefold. The first is to recruit early-career behavioral, biomedical, and social scientists, as well as health care professionals, to conduct high-quality research in the early intervention and treatment of alcohol-related issues. The second is to provide fellows with rigorous interdisciplinary training in addiction science and grant writing through a combination of didactic and practical training and individualized mentorship from leading researchers and clinical scientists. The third is to ensure fellows reach their scientific career objectives by tailoring training opportunities to their unique goals and needs. From its inception, distinctive features of our program include its interdisciplinary nature, focus on training in early intervention and treatment of alcohol-related issues along a continuum, and emphasis on highly individualized opportunities to develop competitive grant applications and, by doing so, contribute new knowledge about alcohol-related dysfunction and treatment. We stress the importance of integrating theory, research, and the latest technologies to advance intervention strategies across development. Fellows gain expertise in the most rigorous and precise experimental and clinical trial methods and learn the most cutting-edge and robust statistical techniques. Across all training activities, we emphasize responsible conduct of research and the importance of scientific rigor and reproducibility. Our unwavering mission is to produce the next generation of addiction scholars focused on innovative research, advanced dissemination and implementation strategies, and public education.

Public health relevance
NARRATIVE This training program is designed to address the significant and costly public health problem of alcohol use disorder by training postdoctoral biomedical, biobehavioral, health care, and other public health scientists to conduct alcohol intervention research. Our program draws on many scientific disciplines, including biological sciences, epidemiology and etiology, prevention, clinical, and public health research, and emphasizes multidisciplinary approaches to achieving innovations in alcohol research. Cutting-edge training of the next generation of alcohol researchers has the potential to accelerate the pace of science in developing effective alcohol treatments.